Inhibition of coronavirus release and mitigate COVID-19 pathogenesis

To characterize the SARS-CoV-2 spike protein interaction with lectin receptors, we have expressed recombinant SARS-CoV-2 spike prefusion trimer using 293F freestyle expression system. Given the nanomolar high affinity of the spike protein binding to human ACE2, the entry receptor for SARS-CoV-2, and the physiological importance of ACE2 in balancing blood pressure, we investigated if this interaction would affect the enzymatic activity of ACE2. Surprisingly, SARS-CoV-2 trimeric spike protein increased ACE2 proteolytic activity 3-10 fold when fluorogenic caspase-1 substrate and Bradykinin-analog peptides were used to characterize ACE2 activity. In addition, the enhancement was mediated by ACE2 binding of RBD domain of SARS-CoV-2 spike. These results highlighted the altered activity of ACE2 during SARS-CoV-2 infection and would shed new lights on the pathogenesis of COVID-19 and its complications for better treatments. A manuscript describing this finding is under revision for publication in Journal of Biological Chemistry.
COVID-induced lung fibrosis is a major confounding factor associated with the current pandemic related death. Understanding the mechanism of COVID-associated lung fibrosis and developing a therapeutic treatment are an urgent public health need to reduce the current pandemic-associated death. Through proteomic analyses of bronchoalveolar lavage fluid (BALF) from COVID patients, we found dramatically elevated levels of fibrinogen and prothrombin in the acute COVID lung fluid compared to the healthy donors. Using primary human bronchoalveolar epithelial cells as models, we discovered that SARS-CoV-2 infected primary lung cells but not other SARS-CoV-2 susceptible cells, including Vero and 293T cells, induced fibrin to clot in the absence of many plasma coagulation factors. Many fibrin fibers induced by SARS-CoV-2 infection originated from lung cells. These infected lung cell induced fibrin clotting occurred with all strains of SARS-CoV-2 pseudoviruses, including omicron, as well as the circulating replication competent SARS-CoV-2 strains tested. They are indistinguishable from those thrombin clots and can be inhibited by pharmacological direct thrombin inhibitors. Importantly, infected lung cells triggered fibrin clotting in 3 of 4 acute but not recovered COVID nor healthy BALF. We suggest the viral infection activated members of cell surface expressed transmembrane serine proteases to directly activate prothrombin for fibrin clotting, as evidenced from the shedding of one of the transmembrane proteases, ST14, in response to the infection, and both recombinant catalytic matriptase and human airway trypsin-like protease activated prothrombin for fibrin clot formation. Our findings revealed a lung cell-mediated fibrosis triggered by SARS-CoV-2 infection that is independent of plasma coagulation, and suggest the need to focus therapeutic treatments to respiratory airway rather than blood vessels to mitigate COVID-induced lung fibrosis.